Non-invasive molecular imaging tool for rapid, longitudinal assessment of localized metabolic disruptions in animal research and care

PROJECT SUMMARY
The cellular pathophysiology that underlies diseases, such as cancer, cardiovascular disease, and diabetes,
begins to change long before disease symptoms become apparent. Moreover, current imaging techniques
typically only visualize morphology and structure. Therefore, imaging techniques that can characterize metabolic
changes have the potential to detect disease processes long before disease symptoms are pronounced.
Metabolic and functional imaging thus allows much earlier diagnosis and treatment. In vivo metabolic imaging,
which distinguishes changes in the chemical reactions that make up cellular processes, can be used to better
understand the mechanisms underlying disease onset and progression. Current metabolic imaging techniques,
such as PET and SPECT, are expensive, difficult, and not conducive for longitudinal studies due to the use of
radioactive contrast agents. Therefore, the broad clinical utilization of these techniques is limited in scope. In
preclinical models, other techniques, such as tissue slicing of sacrificed animals for mass spectrometry analysis,
need to be employed to study cellular metabolism, resulting in a very large translational gap between preclinical
animal models and clinical studies. Vizma Life Sciences has developed a novel easy-to-operate tool to prepare
contrast agents that enable noninvasive, cost-saving, and repeatable in vivo preclinical imaging and is amenable
to clinical translation. The tool prepares hyperpolarized metabolites that can be used as injectable contrast
agents visible to conventional MRI systems. The hyperpolarized metabolites, such as [1-13C]-pyruvate, have
signal-boosted spins and can be tracked in real time and report on metabolic transformations and pathways.
Vizma’s tool can be easily adapted for broad use in animal facilities and in longitudinal studies in the same
animals, thus reducing experimental variability and the number of animals required as the animals do not need
to be sacrificed for metabolic imaging. This tool will directly improve the translation of animal research to clinical
validation. The overall goal of this Phase I SBIR is to make the Vizma hyperpolarization process fully
biocompatible. This involves adapting the [1-13C]-pyruvate hyperpolarization process from an alcohol-based
solution to an aqueous solution, determining sensitivity limits, and then measuring residual solvent and catalyst
contamination. The in vivo feasibility and safety of the technology will be examined by assessing the levels of
detection of acute injections of the aqueous solution with chemical shift imaging in animals and monitoring
another set of animals receiving hyperpolarized injections of the aqueous solution once a week for two weeks.
Successful completion of this Phase I SBIR will result in in vivo proof-of-concept and support Phase II
investigations of its use in imaging multiple animal models of disease in multiple species. The ultimate goal of
this project is to commercialize this technology for broad use in preclinical and clinical settings.

Public health relevance
PROJECT NARRATIVE Because disease-related alterations in cellular mechanisms occur long before disease symptoms, in vivo imaging of biomolecular transformations can be used to detect cellular dysfunction at an early pre-diagnosis stage, be it in preclinical animal models or a clinical setting, and thereby provide a better understanding of the onset and progression of disease mechanisms. Current cellular imaging techniques are expensive, difficult, and often require radioactivity, thus limiting their use in research animal models and clinical practice. In this proposal, we examine the safety and feasibility of our novel easy-to-operate tool that is used to prepare contrast agents for metabolic imaging in research animal models and that has a clear path to clinical translation because it enables safe longitudinal visualization of biochemical cellular mechanisms and metabolic pathways in any organ for early stage detection and in-depth monitoring of disease.